FEEDBACK ACTIONS OF CORTISOL ON ACTH RELEASE IN MEN

The nature of the feedback regulation of ACTH release by cortisol will be tested in normal men. Women are being studied similarly in a collaborating GCRC. We will administer a potent inhibitor of adrenal steroidogenesis before and then with concomitant pulsatile or continuous intravenous delivery of cortisol over 24hrs. This will tell us if a pulsatile cortisol signal shuts off ACTH secretion more efficiently.